Living electrodes for auditory rehabilitation.

Hearing loss affects over 28 million Americans and is the second most common disability in the Veteran
population. For hearing loss too severe to be helped by hearing aids, cochlear implants have become the
standard of care. Though they can restore the ability to understand speech for many, current electrodes have
poor selectivity for neuronal excitation. This limits fidelity leading to difficulty with background noise, talking on
the phone, and music appreciation. Researchers at the Center for Neurotrauma, Neurodegeneration, and
Restoration (CNNR) at the CMC-VAMC have pioneered biologically-based neural interfaces with neuron-
specific stimulation that have yet to be applied to hearing restoration. This project utilizes transplantable living
scaffolds for the rehabilitation of hearing through biohybrid neural interfaces.
Biohybrid neural interfaces will be developed that allow transplanted spiral ganglion neurons (SGN) to remain
accessible to stimulation while their axons interact with neurons of the central auditory pathway or cochlea –
creating a “living electrode”. SGN will be harvested from neonatal rat temporal bones and the cells’ ability to
stimulate a distinct population of SGN (cochlear implantation), and centrally derived neurons (brainstem
implantation) will be confirmed in culture. Light activated opsins will also be induced to allow for optical
stimulation. SGNs will then be grown on two distinct scaffolds in vitro. The first directs transplanted SGN axons
to the inferior colliculus in the brainstem, and the second directs them from the round window of the cochlea to
the native spiral ganglion. Both designs allow for electric and optical stimulation of the transplanted SGN cell
bodies. Once transplanted into living rats, cell survival and integration are evaluated with
immunohistochemistry at various timepoints for up to 6 months. Electrophysiologic recordings from the auditory
cortex will be obtained in deafened rats implanted with either the brainstem or cochlear scaffolds, while being
stimulated either electrically or optically. Behavioral models will then used to evaluate the auditory perception
induced via stimulation of the living scaffolds.
The final product of this project will be two form-factors of living electrodes for hearing rehabilitation, one for
implantation into the inferior colliculus and one for implantation into the cochlea. It is expected that the neuron-
specific simulation permitted by this technique will allow for precision in stimulation of the auditory system that
cannot be approached by current implant technology.
This is a resubmission of a new proposal.
This work is directly translatable to improved implantable hearing devices for those with hearing loss too
severe to be adequately rehabilitated with traditional hearing aids. Improvement in the rehabilitative options for
these veterans will have a significant impact on their quality of life and well-being.
Not only does the proposed work advance a next generation, biologically based interface to restore the ability
to interpret sophisticated auditory inputs in our Veterans, as a Career Development Award, it will also serve as
vehicle to expand my technical skills in tissue engineering and regenerative therapies. This CDA will form the
foundation of a career in pushing the boundaries of hearing restoration.

Public health relevance
Hearing loss and tinnitus are the most common service-related disabilities for veterans. These disabilities span decades, conflicts, geographic location, and job descriptions. For those patients who have hearing loss too severe to benefit from hearing aids, cochlear implants offer a chance to regain some hearing and even understand speech without reading lips. However, current electrode technology cannot approach natural hearing. We propose applying living scaffold technology to the central and peripheral auditory system to create an implantable hearing device that provides more natural hearing than is possible with current technology. Living electrodes will be created by growing spiral ganglion neurons on to constructs designed to be implanted in the cochlea or auditory nuclei in the brainstem. These studies promise to deliver a significant advance in the ability to restore hearing to veterans, and people around the world.